Revealing the Mechanisms of Cleaved and Intact GSDMD Pore Formation and Membrane Rupture

ABSTRACT
Humans are exposed to hundreds of millions of pathogens daily. The innate immune system is one of two
immune arms and the first line of host defense. It quickly recognizes danger stimuli: damage-associated
molecular patterns (DAMPs) and pathogen-associated molecular patterns (PAMPs). Sensor proteins including
NLRP3 (nucleotide-binding oligomerization domain (NOD)-, leucine-rich repeat domain (LRR)-, and pyrin
domain-containing protein 3) can detect PAMPs and DAMPs, resulting in the activation of supramolecular
protein-signaling complexes called the NLRP3 inflammasome. Upon stimulation, NLRP3 interacts with the
centrosomal NIMA-related kinase 7 (NEK7) and oligomerizes into a complex essential for recruiting the ASC
adaptor protein, generating functionally active NLRP3 inflammasome. The assembled NLRP3 inflammasome
specks recruit and activate caspase-1, a protease that cleaves pro-inflammatory cytokines interleukin (IL)-1β
and IL-18 generating active cytokines. In addition to cytokine activation, caspase-1 cleaves the pore-forming
protein gasdermin D (GSDMD), facilitating GSDMD-dependent pyroptotic cell death and secretion of IL-1β and
IL-18 to release inflammatory signals. While imperative to the inflammatory response and host defense, aberrant
hyperactivation or gain-of-function mutations in inflammasome proteins can cause constitutive cytokine
activation and pyroptosis, leading to human diseases such as inflammatory bowel disease, cardiovascular
disease, gout, and other rare autoinflammatory disorders. Moreover, inhibiting the inflammasome pathway is a
therapeutic strategy for preventing lethal septic shock. Despite its therapeutic potential, many mechanistic details
underlying the activation of inflammasomes remain unknown. Herein, I propose to elucidate the molecular
mechanisms underlying the activation and regulation of the inflammasome executioner protein GSDMD. I aim to
interrogate this complex system through a combination of biochemistry, biophysics, and cell biology. Completion
of these independent aims will illuminate the mechanisms of how GSDMs are regulated and exert their pore-
forming activity, which will not only provide new insights into pyroptosis but also afford new therapeutic strategies
for treating inflammasome-related and pyroptosis-related diseases.

Public health relevance
PROJECT NARRATIVE GSDMs are associated with many human diseases, and deletion of GSDMD significantly decreases pyroptosis and remarkably protects mice from sepsis. Genetic mutations in GSDMA3, GSDME, or DFNB59 cause alopecia and hyperkeratosis in mice and nonsyndromic hearing loss in humans, while polymorphism of GSDMB is linked to increased asthma and IBD risk. Elucidating the structural mechanism of pore formation by GSDMs will have a substantial impact on generating potential therapeutics against these diseases.